CONFORMATIONAL CHANGES IN THE HIV ENVELOPE GLYCOPROTEIN

Enveloped viruses deliver their genomes to cells by fusing with cellular membranes. This fusion process is mediated by viral envelope glycoproteins when they undergo conformational changes while binding target cells. For many viruses, including HIV, receptor binding triggers conformational changes in the envelope glycoprotein that are required for mediating membrane fusion required for entry. Our research aims to elucide the roles of CD4 and chemokine receptors in triggering conformational changes in the HIV envelope glycoprotein required for entry. We are focusing on how the receptors affect the structure of the helical regions in gp41 that we have shown to undergo conformational changes critical for HIV entry (Furuta, et al Nature Structural Biology, 1998). Using peptides we have found that envelope glycoproteins from different strains use receptor differently for triggering conformational changes. We are sorting out how receptor usage correlates with conformational changes, envelope glycoprotein stability, and fusion phenotype (syncytia-inducing or non-inducing strains).